Lipid-initiated epigenetic reprogramming of the breast to a neural phenotype

Project Summary
The known determinants of risk for estrogen receptor (ER)-negative breast cancer are genetic or
systemic/behavioral factors. In contrast, few if any local factors in the breast environment serve to identify
women at risk for ER negative tumors. Local in-breast factors are of great interest however, since they may be
more specifically targetable for breast cancer prevention than systemic factors. In this innovative submission,
we propose that the expression of neural genes, a recently identified “Hallmark of Cancer”, results from
epigenetic reprogramming consequent to lipid-induced altered metabolic flux.
Studies of metachronous breast cancers that develop in the opposite breast show a similarity to the ER status
of the index primary. Therefore, we employed the contralateral unaffected breast (CUB) of women undergoing
surgical therapy for newly diagnosed unilateral breast cancer as a model to discover potential markers of ER-
risk. In a previous study, we identified a lipid metabolism (LiMe) gene signature, which was enriched in the
CUBs of women with ER- breast cancer.
In order discover mechanisms by which lipid metabolism pathways would aid ER- breast cancer development,
we established an in vitro model in which the ER and progesterone receptor (PR) negative cell lines MCF-
10A/12A and breast microstructures are exposed to octanoic acid (OA), a medium chain eight-carbon fatty
acid. Using this model system, we observed dynamic and profound changes in gene expression,
accompanied by changes in chromatin packing density, chromatin accessibility and histone methylation.
Significant increase in metabolic flux was observed in 38 reactions, among them those of the serine, one-
carbon, glycine (SOG) pathway and the methionine cycle with a consequent increase in S-adenosylmethionine
(SAM) concentration. An intriguing and unexpected finding was expression of genes involved in nervous
system development, which we hypothesize results from SAM driven histone methylation. We propose to
pursue these provocative results as follows. Aim 1 explores whether the OA-mediated increase in the
expression of specific neural genes is also observed at the protein level. Based upon gene expression, a
specific subset of basal cells (BSL1) are hypothesized to be those undergoing the epithelial to neural flip.
BSL1 will be isolated from breast microstructures, exposed to OA and assayed for neurite outgrowth. Aim 2’s
goal is to determine which other histone methylations are responsible for the increased expression of genes
associated with neurons and decreased expression of those associated with epithelial cells. Aim 3 is
constructed to determine whether specific SNPs associated with ER-breast cancer produce a
microenvironment in vivo that mirrors the OA rich experimental environment. These investigations have the
potential to reveal a set of novel metabolic-fostered alterations that may be utilized as targets for breast cancer
prevention.

Public health relevance
Project Narrative Determining the etiologic/biologic factors that favor the development of Estrogen Receptor Negative (ER-) Breast Cancer will potentially enable the development of both strategies to identify women at risk for ER-negative disease as well as targeted preventive and therapeutic agents. This is a significant unmet clinical need.